Identifying the mechanism of anti-colorectal immunity induced by mucoinvasive colonic bacteria

Abstract
Colorectal cancer (CRC) is a leading cause of cancer-related death and its incidence is on the rise in young
people. Colorectal tumors are often detected at late stages where therapy often fails. Immunotherapy is
revolutionizing the treatment of many types of cancer but is only effective for a very small subset of CRC patients.
Thus, there is a critical need for improved therapies for CRC. Colorectal tumors grow from the intestinal
epithelium and interact with the colonic microbiota. CRC has been associated with shifts in the composition of
the microbiota that promote inflammation and tumor growth. The microbiota can also shape colonic T and B cell
immune responses and is a critical modulator of the efficacy of tumor immunotherapy. Using a mouse model of
CRC (AOM/DSS) we show that colonization with a single bacterial taxon: Helicobacter hepaticus, after tumors
have already developed, leads to a reduction in tumor burden and size. H. hepaticus also increased the number,
size and organization of Tertiary lymphoid structures (TLS) next to colorectal tumors. The presence of TLS is
associated with positive outcomes in CRC patients, but how they act to increase anti-tumor immunity is not
known. H. hepaticus-dependent tumor reduction depended upon CD4 T cells and B cells but not CD8 T cells.
Most H. hepaticus-specific CD4+ T cells differentiated into T Follicular Helper (TFH) cells and localized in TLS.
Importantly, CD4cre Bcl6flox mice, that cannot form TFH cells, also failed to either form TLS or control CRC growth,
but transfer of H. hepaticus-specific CD4+ T cells completely restored the anti-tumor response. Our hypothesis
is that the distinct mucus colonization properties of Hhep leads to activation of anti-Hhep TFH that interact with B
cells to induce peri-tumoral TLS formation. Colonic TLS then act as platforms for the activation of anti-tumor
CD4+ T cells, NK cells and B cells which invade the tumor to support effective anti-tumor immunity. We will test
this hypothesis in two aims. First, we will identify the genes and behavior, (such as mucus/epithelial colonization)
associated with Helicobacter-associated control over CRC. Next we will correlate the presence of TLS, TFH and
B cells in human CRC patients with specific mucus and tumor resident bacteria. Finally, we will use our mouse
models to identify whether TLS serve as platforms for more effective activation of anti-tumor T and B cells.
Together, our proposal has the potential to identify the key bacterial components that should be targeted to
augment anti-tumor immunity and colonic TLS. Further we may identify mechanisms by which TLS support anti-
tumor immune responses which could be used to formulate therapeutic anti-CRC approaches. If successful we
could identify mechanisms to rationally modify the microbiome to increase anti-tumor immunity.

Public health relevance
Project Narrative Colorectal cancer remains a common and deadly disease that is on the rise amongst young people worldwide. Colon tumors grow adjacent to the intestinal microbiome and bacteria from the microbiome can both drive tumor growth and also support the activation of anti-tumor immunity. Our proposal seeks to identify colonic bacteria that most activate colonic immune cells and define how immune cells become activated to kill tumors.